FUNCTION &INHIBITION OF P PALCIPORUM DIGESTIVE VACNOLES

The purpose of this research is to understand the functioning of the malaria parasite digestive vacuole and to develop inhibitors. The mass spec. analysis was performed to characterize a cysteine protease inhibitor to be used for trying to inhibit processing/activation of an aspartic protease that is crucial for hemoglobin degradation.